Analysis of cord blood Vd2 T cell differentiation and function using CITE-seq and ATAC-seq

PROJECT SUMMARY
Infants are especially susceptible to infectious agents, in particular intracellular pathogens, which require
mounting a Th1 response for immune protection. The fact that CD4 T cells before birth and in early life
are inherently skewed in favor of T regulatory or Th2 responses contributes to this clinical outcome and helps
explain why infections are a leading mortality cause among children under the age of 5 years.
Contrary to CD4 T cells, innate-like Vγ9Vδ2 (Vδ2) T cells are poised to secrete Th1 cytokines even before
birth and acquire potent cytotoxic function shortly after birth. They mount rapid responses against a broad array
of pathogens, including protozoa, bacteria and viruses, by sensing microbial intermediates of cholesterol
biosynthesis in an MHC-unrestricted manner. Additionally, they can be activated by innate cytokines such as IL-18 and IL-15, secreted by myeloid cells during infections. Despite these key antimicrobial features, Vδ2 cell role
against pathogens in early life is understudied and our ability to harness their potential is very limited. Our long-
term goal is to fill this gap in knowledge and exploit Vδ2 cells to improve vaccine responses in infants.
We recently observed that the inhibitory receptor PD1, which we know serves as a key regulator of Vδ2 cells
at birth, appears to mark cells that are unlikely to have developed cytotoxic potential. Specifically, both ex vivo
and after expansion, cord blood PD1+CD56- Vδ2 cells contain the lowest proportion of perforin+ cells among the
four subsets identified by concomitant assessment of the two markers, while the PD1-CD56+ subset contains the
highest. Bulk RNA sequencing performed on sorted Vδ2 cell subsets after in vitro expansion validated the flow
cytometry findings. We hypothesize that expression of PD1 in neonatal Vδ2 lymphocytes, especially in absence
of CD56, marks cells with specific functional features, possibly representing a unique differentiation state.
With the help of key collaborators, we aim to test our hypothesis with existing cord blood samples and assess
feasibility and effectiveness of state-of-the-art single cell approaches to study ex vivo sorted Vδ2 cells. We will
rely on Cellular Indexing of Transcriptomes and Epitopes by sequencing (CITE-seq) and a variation of the Assay
for Transposase-Accessible Chromatin with sequencing (ATAC-Seq), called ATAC with Select Antigen Profiling
by sequencing (ASAP-seq), to investigate the significance of PD1 for Vδ2 cell differentiation and function. We
will perform paired CITE-seq and ASAP-seq analyses to address two aims: Aim 1) Compare the transcriptional
profile of ex vivo sorted Vδ2 cells at a single cell level using a CITE-seq approach; and Aim 2) Compare
the chromatin accessibility profile of sorted PD1+ and PD1- Vδ2 cells by ASAC-seq.
This study will advance our understanding of Vδ2 cell function in early life. The results of the proposed
research will inform future studies, including a proposal aimed at investigating the impact of maternal placental
malaria on infant Vδ2 cells, which may serve as biomarkers of higher (of lower) risk of malaria in early life.

Public health relevance
PROJECT NARRATIVE Neonates and infants are highly susceptible to infections, particularly those caused by intracellular pathogens, because their protective CD4 T helper 1 responses have not reached adult levels. A subset of Innate-like T cells, unlike conventional CD4 T cells, are poised for rapid Th1 responses in early life, and may have protective roles against intracellular pathogens, but our understanding of their function in infants is limited. We propose an approach based on the analysis of transcriptional and chromatin accessibility profiles in the cord blood innate- like cells to study their function, with the long-term goal of learning how to harness their potential to improve infant responses to vaccines.